Mechanisms that control neuronal microtubule polarity

PROJECT SUMMARY
Tightly regulated microtubule dynamics and polarity are essential for long-term survival of neurons.
Nucleation of new microtubules in axons and dendrites contributes to dynamics and polarity and is also
critical for neuroprotection and dendrite regeneration. In a previous study, Wnt signaling proteins on
endosomes were shown to control microtubule nucleation in dendrites. The current proposal expands on this
finding to answer fundamental questions about neuronal microtubule organization and the relationship
between cell shape and regional specialization. Proposed experiments analyze neurons in their normal
environment and rely on the powerful genetic tools available in the Drosophila model system.
Aim 1. Do surrounding cells control neuronal microtubule nucleation? The finding that Wnt signaling
proteins, including four receptors, are required to position nucleation sites in dendrites raised the possibility
that ligands from surrounding cells could control neuronal microtubule dynamics. Preliminary data suggests
that epithelial cells that contact dendrites are the Wnt source. Aim 1A focuses on confirming that epithelial
Wnts regulate neuronal microtubule nucleation. In Aim 1B the potential that Wnt signaling could tune
nucleation to help neurons respond to injury will be explored.
Aim 2. How are nucleation sites targeted to branch points? The distribution of Wnt signaling endosomes
that control nucleation is non-random in dendrites: they are typically positioned at dendrite branch points. This
localization links neuronal structure directly to regulation of microtubule dynamics. In Aim 2A several different
hypotheses about how Wnt signaling endosomes are localized to branch points will be tested. Potential
mechanisms that could contribute to targeting include local delivery of Wnt receptors or ligands and local
endocytosis. Preliminary data indicates endocytic sites are enriched at dendrite branch points. In Aim 2B this
preliminary data will be used to ask how branch points are recognized as different from the rest of the cell by
the endocytic machinery. Two hypotheses that will be tested are: 1) membrane curvature-recognizing proteins
recruit endocytic proteins to branch points, and 2) the tight curvature of the plasma membrane outside branch
points mechanically restricts endocytosis to branch points.
Aim 3. Axonal parallels: Is axonal microtubule nucleation the same as dendritic? While studies in
invertebrate model systems have provided insights into how microtubules are nucleated in dendrites, these
systems have not yet been used to probe axonal nucleation. In Aim 3A, a sensitized nucleation assay will be
used to determine whether any dendritic nucleation regulators also function in the main axon shaft. In Aim 3B,
nucleation at the neuromuscular junction will be investigated.
Summary: Neuronal microtubule nucleation is still poorly understood, and the proposed experiments will
substantially advance our understanding of this fundamental aspect of neuronal cell biology.

Public health relevance
PROJECT NARRATIVE Neurons use the microtubule cytoskeleton as the tracks to transport building blocks to distant parts of the cell. For microtubules to be maintained over long distances in axons and dendrites, they need to be locally generated by nucleation. The goal of this project is to understand how nucleation is controlled in axons and dendrites, and whether surrounding cells regulate neuronal microtubule dynamics through nucleation.